Point-of-Care Diagnostic for Spontaneous Bacterial Peritonitis

PROJECT SUMMARY
Spontaneous bacterial peritonitis (SBP) is a frequent and severe complication of liver disease, in which an
infection occurs in the ascitic fluid of the peritoneal cavity without an identifiable source of infection. Chronic
liver disease is a leading cause of mortality and affects over 120 million people worldwide. Hospitalizations
resulting from complications of chronic liver disease carry an economic burden of over $80 billion annually in
the US, with the majority of these resources directed towards patients with cirrhosis. SBP affects around 10-
30% of patients hospitalized with cirrhosis and ascites and carries a substantial in-hospital mortality rate
ranging from 17 to 30%. Prompt diagnosis and treatment are critical to prevent potential complications,
including renal failure and sepsis. SBP is diagnosed when the polymorphonuclear leukocyte (PMN, also known
as granulocytes) count is 250 cells/mm3 or greater. Currently, it can take days to diagnose SBP after
presentation of symptoms, with testing delays leading to significantly increased mortality. Diagnosis without
PMN is ineffective, as approximately a third of patients presenting with ascites lack any additional symptoms to
indicate SBP. A rapid point-of-care (POC) diagnostic tool would enable immediate clinical decision-making,
facilitating prompt initiation of antibiotic therapy and enhancing the overall management of SBP. We propose
an innovative methodology building upon our recent breakthrough in label-free deep ultraviolet (UV) assay
technology. This approach integrates microfluidic-based sample preparation and advanced algorithm-driven
cell classification, facilitating on-the-spot cell counting in ascitic fluid. Our earlier research successfully utilized
label-free deep UV microscopy for comprehensive 5-part white blood cell differentials, red blood cell
quantification, and platelet identification in peripheral blood samples. The imaging system, characterized by a
straightforward optical path, allows differential cell analysis using images captured from a single wavelength
LED light source. Pseudo-colorized UV images, derived from deep-UV microscopy, have demonstrated
diagnostic efficacy equivalent to the gold standard Giemsa-stained images in manual blood cell differentials.
Leveraging our proprietary cell segmentation and classification algorithms, we can analyze these images to
categorize various blood cell types, enabling automated differentials in ~3 minutes. This pioneering approach
holds significant promise for the development of a POC SBP diagnostic with equivalent accuracy to a clinical
pathology lab. In Phase I of this project, we propose to 1) visualize and identify PMNs and red blood cells
(RBCs) in ascitic fluid using deep-UV microscopy and 2) automate the cell identification and classification
using a machine learning-based algorithm. Phase II efforts will focus on optimization of sample preparation and
translation of our prototype instrument into a user-friendly device. Successful commercialization of this device
will enable faster diagnosis of SBP, which is critical for reduction of mortality.

Public health relevance
PROJECT NARRATIVE Prompt diagnosis and treatment are critical for survival of spontaneous bacterial peritonitis (SBP), with each hour delay in treatment resulting in a 3.3% increase in in-hospital mortality. Cellia Science will develop the first point-of-care device for diagnosis of SBP at the patient bedside. Successful implementation of this device is expected to reduce patient mortality by decreasing the time until a patient receives antibiotic treatment.